Neuromodulation of Brain States

PROJECT SUMMARY
The monoamines, which include dopamine, norepinephrine, and serotonin, are evolutionarily conserved
neurotransmitters that modulate the activity of excitatory and inhibitory neurons throughout the entire brain,
and are thus essential for diverse aspects of physiology and behavior. Abnormalities of monoamine
systems contribute to numerous brain disorders including schizophrenia, depression, and Parkinson's
disease. We recently developed viral-genetic tools to determine the input, output, and input–output
relationships of a given neuronal population at the scale of the entire mouse brain, and discovered
contrasting input–output architectures between locus coeruleus norepinephrine neurons and midbrain
dopamine neurons. Here, we apply these tools to study the organization and function of the dorsal raphe
(DR) serotonin system, which provides major serotoninergic input to the forebrain to regulate diverse
.
functions and brain states including mood, impulsivity, anxiety, as well as hunger and thirst.
Using rabies-mediated trans-synaptic tracing, we previously defined the input architecture to the entire
populations of DR-serotonin and DR-GABA neurons However, our unpublished work revealed
considerable heterogeneity within the DR serotonin system and suggests that it consists of parallel sub-
systems that differ in input, output, and neurotransmitter phenotypes. We propose that each DR serotonin
sub-system may carry out a specific subset of the diverse functions ascribed to the DR-serotonin neurons.
We plan to complete our characterization of the anatomical organization of the DR serotonin sub-
systems, addressing the questions of how axons of each sub-system divide up the projections of the entire
DR serotonin system, and what is the input–output relationship for each DR serotonin sub-system. These
will lay a foundation for all future studies of DR-serotonin neurons. We also propose to identify behavioral
functions of a subset of these sub-systems by manipulating and recording serotonin neuron subtypes in
anxiety- and depression-like states known to involve serotonin, as well as new behavioral paradigms.
Finally, because previous studies and our own unpublished data suggest a strong link between serotonin
and thirst, we will explore the circuit and cellular mechanisms by which serotonin regulates thirst-motivated
behavior using quantitative and sensitive assays we have established based on a technique we developed
to gain genetic access of thirst-activated neurons. The integration of anatomical, physiological, and
behavioral studies on genetic-, projection-, and activity-defined neuronal populations proposed here will
help dissect the complex serotonin system into specific sub-systems and advance our understanding of
how serotonin modulates diverse physiological functions and behaviors.

Public health relevance
Project Narrative Abnormalities of the serotonin neuromodulatory system contribute to human mood, anxiety, and many other disorders that greatly impact the society. Our proposed experiments integrate modern anatomical, physiological, and behavioral techniques to help dissect the complex serotonin systems into specific sub-systems. This will advance our understanding of how serotonin modulates diverse physiological functions and behaviors.